Toxoplasma sporozoite genes that determine environmental resistance and invasion of host cells.

Project Summary
The parasite Toxoplasma gondii can cause severe disease in immunocompromised patients and fetuses and
is the second leading cause of foodborne deaths in the USA. Infection starts after ingestion of oocysts shed in
cat feces or after ingestion of meat contaminated with tissue cysts. Oocysts are extremely stable in the
environment, resistant to the most inactivation procedures, and highly infectious. Because livestock get
infected by sporozoites derived from oocysts, a vaccine based on sporozoites or sporozoite proteins could be
effective in protecting livestock and humans. Currently, the only vaccine available is a live attenuated vaccine
only approved for use in sheep. However, this vaccine has serious shortcomings as the genetic basis for the
attenuation is not known, which poses reversion risks, and it needs to be used immediately once produced
because it is based on live tachyzoites, which are not viable for long outside host cells. Despite being a critical
step for Toxoplasma transmission, sporozoites inside oocysts are under-studied, largely because they are not
cultivatable in vitro and difficult to access in vivo. There is, therefore, a critical need to identify sporozoite gene
products that are critical for its invasion of host cells, which could lead to the discovery of vaccine targets.
Furthermore, if the genetic basis for the extreme environmental resistance of sporozoites was known it might
be possible to exploit this to make other Toxoplasma life stages, such as tachyzoites, or other pathogens more
viable extracellularly, which could enhance the shelf-life of vaccines based on live parasites. Our overall
objectives are to identify Toxoplasma genes that are specifically involved in the environmental resistance and
infectivity of sporozoites. Our central hypotheses are that 1) sporozoite-specific micronemal proteins (MICs)
are critical for their invasion into host cells; 2) late embryogenesis abundant proteins (LEAs), which are known
to provide resistance to environmental stresses such as drought, high salinity, and freezing in a variety of
organisms, determine sporozoite resistance to environmental stressors. In our first aim we will determine the
role of LEAs in the protection of sporozoites against environmental stressors. In our second aim we will test the
hypothesis that MICs that are specifically expressed in sporozoites are involved in the invasion of host cells.
The identification of sporozoite genes that play a role in extracellular survival and attachment/invasion of host
cells, will pave the way for designing vaccines that can prevent Toxoplasma infection of humans and animals.

Public health relevance
Project Narrative Environmentally resistant oocysts containing infectious sporozoites from the protozoan parasite Toxoplasma gondii are a major cause of human infection and responsible for major outbreaks of toxoplasmosis leading to ocular diseases, and severe pathology and death in immunocompromised patients and fetuses. In this project we will identify sporozoite gene products that are critical for the invasion of host cells, which could lead to the discovery of vaccine targets that could prevent livestock and humans from getting infected by this critical Toxoplasma life stage. We will also determine the genetic basis for the extreme environmental resistance of sporozoites, which could be exploited to make other Toxoplasma life stages, such as tachyzoites, or other pathogens more viable extracellularly, which could enhance the shelf life of vaccines based on live parasites.